Machine Learning for Drug Response Prediction

Abstract
Modeling cell type-specific responses to drugs is an important yet challenging topic in drug
development and personalized medicine. Our research program has developed a suite of algorithms for
predicting cell-line level drug responses, and seeks to address the next-step questions in improving the
transferability of predicting cell type-specific and combinatorial drug responses. Our goal over the next five
years is to tackle the following three major challenges that hinder the transferability of drug response
models. The first challenge is delivering drug response models across datasets generated by different
platforms and labs. The second challenge is transferring drug response predictions from in vitro systems
to humans. The third challenge is the heterogeneity of the samples, which can hinder the effectiveness of
targeted therapy due to the acquisition of mutations and the evolution of tumors to evade the immune
system. To address these challenges, we will focus on improving the robustness of models across
datasets by establishing coherence networks of drugs. We will leverage and fine-tune large language
models to refine our collection of literature-based drug information and extract new features for drugs. We
will also explore the possibility of using the heterogeneity of the samples to improve the accuracy and
robustness of drug response models. Overall, we envision that our research program will contribute to
personalized medicine and expedite the drug development process.

Public health relevance
PROJECT NARRATIVE Molecular targeted therapy has emerged as a promising approach for combating complex human diseases. Nonetheless, discovering effective, personalized small-molecule drugs presents a significant challenge. This research program aims to address this challenge by investigating transferable, cell type-specific drug response and combinatorial response models, and therefore provides valuable tools for guiding drug development efforts.